The PREVENTABLE Physical Performance Ancillary Study

Project Summary/Abstract
Aging is associated with significant declines in muscle mass, strength, and physical performance, which often
lead to disability, loss of independence, and adverse clinical outcomes including multimorbidity and mortality.
At present, health care providers have no therapeutic options to offer their patients to slow aging-related
declines in physical function. Importantly, evidence is emerging that statins could be an effective treatment for
preserving physical function by preventing disabling events such as stroke, heart failure, or myocardial
infarction. In addition, statins have pleiotropic properties including anti-inflammatory, anti-oxidant, and immuno-
modulatory effects, which may slow or prevent aging-related declines in physical function. However, reports of
muscle pain and weakness in patients on statins has led to a significant number of patients discontinuing
statins. Thus, the proposed study is critical to establish whether statins may help to preserve physical function
and independence in older adults, or whether statin-associated muscle symptoms portend a statin-related
decline in physical function. The PREVENTABLE trial (U19 AG065188) provides an ideal opportunity to
definitively determine the effect of statins as a treatment for aging-related declines in physical function.
PREVENTABLE is a placebo-controlled pragmatic clinical trial designed to investigate whether randomization
to a statin can prevent dementia and prolong disability-free survival in 20,000 participants aged 75+ years
without clinically evident coronary heart disease. While the PREVENTABLE trial will help clarify the effects of
statins on self-reported disability, the proposed ancillary study will extend and validate the physical disability
data by investigating the effects of statins on changes in physical performance, which are typically observed
earlier in the trajectory of functional decline and may be a more sensitive marker for the effects of statin. To
determine if statins affect longitudinal change in physical performance, the proposed ancillary will add the
Short Physical Performance Battery (SPPB), a validated measure of lower-extremity performance comprised of
balance tasks, a 4-m walk, and repeated chair stand test, over 3 years of follow-up in 2,500 PREVENTABLE
participants (1,250 per intervention arm). Self-reported information on patient-centered outcomes relevant to
physical function including statin-associated muscle symptoms, fatigue, and pain will also be collected. The
specific aims of this ancillary study are to: 1) determine whether randomization to statin slows the aging-
related decline in usual gait speed; 2) determine whether randomization to statin slows aging-related declines
in lower-extremity function (SPPB score) and strength (chair rise time); and 3) explore whether randomization
to statin is associated with self-reported statin-associated muscle symptoms, fatigue, and pain. By leveraging
the rich resources and infrastructure of PREVENTABLE, this timely and cost-effective study provides a unique
opportunity to significantly expand the scope and impact of the parent trial on self-reported physical disability
by determining the therapeutic potential of statins to slow aging-related declines in physical performance.

Public health relevance
Project Narrative Aging is associated with significant declines in muscle mass, strength, and physical performance, all of which lead to disability, loss of independence, and poor clinical outcomes. Currently, health care providers have no treatment options to offer their patients to slow declines in physical function. Evidence suggests that statins could be an effective treatment for preserving physical function by preventing disabling chronic conditions; however, a large number of patients discontinue statins because of side effects including muscle pain and weakness. Thus, determining whether statins can preserve physical function and independence in older adults is needed to inform treatment guidelines for the use of statins in older adults.